A novel method for volumetric oxygen mapping in living retina

PROJECT SUMMARY
It is widely accepted that oxygen deficiency is a culprit and a marker of several major retinal diseases,
including diabetic retinopathy, age-related macular degeneration, glaucoma etc. However, it remains to be
extremely challenging to measure oxygen in vivo in the eye, and no tools currently exist that can provide 3D
oxygen distributions in the retina with high spatial resolution at appropriate imaging speeds. The goal of this
project is to overcome these limitations and develop a new optical imaging technique for volumetric oxygen
mapping in retina. Our approach will leverage the recently developed potent oxygen probes (such as Oxyphor
2P), whose phosphorescence decay times serve as quantitative markers of local oxygen partial pressures (pO2)
in living tissues. To enable volumetric imaging with high throughput, we propose to develop a novel imaging
instrument, termed oblique scanning laser ophthalmoscope (oSLO). oSLO is based on the concept of single
lens scanned light sheet microscopy and enables volumetric phosphorescence lifetime imaging without time-
consuming plane-by-plane pixel-wise sectioning. Our new method should be able to achieve 10 kilohertz voxel
rate that is three orders of magnitude higher than the current state-of-the-art two-photon phosphorescence
lifetime microscopy (2PLM). In this project we will: (Aim 1) develop a phosphorescence lifetime-based oSLO
for volumetric pO2 mapping in living retina in mouse. The new design will allow parallel detection of signals at
depth from each scanned location, so that the need in conventional depth sectioning is eliminated and imaging
throughput is greatly increased. We will (Aim 2) dynamically image responses of retina and choroid to systemic
hypoxia challenge using Oxyphor 2P. We will (Aim 3) then bridge oSLO measurements and label-free
applications by multimodal imaging with visible light optical coherence tomography (vis-OCT). Using vascular
pO2 as the ground-truth, we will develop a deep spectral training (DSL) algorithm to supervise the inverse
calculation of vis-OCT for robust and reliable label-free retinal oximetry. This study will enable the first direct
quantitative imaging of interactions between the two circulatory systems in retina (i.e. retinal and choroidal
circulation), providing unprecedented information about retinal oxygen supply. IMPACT ON PUBLIC HEALTH:
Successful completion of this program will deliver a new ground-breaking methodology for mapping oxygen in
the retina that will greatly improve our understanding of retinal diseases.

Public health relevance
NARRATIVE Oxygen is essential in the retina, and the deficiency of oxygen is a culprit in a broad spectrum of retinal diseases. However, it remains challenging to measure oxygen in vivo in the eye. This multidisciplinary proposal is to develop a disruptive imaging method to provide unprecedented volumetric oxygen mapping in living mouse retina, as well as a deep learning method, to translate our oxygen measurements into label-free retinal oximetry for future clinical applications.